Cortico-Amygdalar Substrates of Adaptive Learning

ABSTRACT
Individuals with Substance Use Disorder (SUD) often exhibit increased stochasticity in their choice behavior,
indicating an inability to adopt a consistent internal model and/or an appropriate rate of learning. Tackling
uncertainty related to model adoption requires the brain to estimate the reliability of different internal models
and arbitrate between these models. These processes, however, are not well understood mainly because in
most experimental paradigms only a single type of reward contingency is tested such that either stimuli or actions
predicts reward, not both. Additionally, the rate of learning is affected by other types of uncertainty in the
environment: (1) expected uncertainty due to the probabilistic nature of reward outcomes, and (2) unexpected
uncertainty due to actual changes in the reward environment. Interestingly, subregions of prefrontal cortex (PFC)
are involved in both stimulus- and action-based learning, and in learning under uncertainty. For example, both
orbitofrontal cortex (OFC) and anterior cingulate cortex (ACC) seem to be similarly engaged in learning under
uncertainty while their activity reflects stimulus and action values, respectively. Although ACC and OFC
subregions of PFC are both involved in adaptive behavior, they may serve different functions. Densely
interconnected with both OFC and ACC, the basolateral amygdala (BLA) is also involved in adjusting behavior
when the environment changes. However, it is unclear how BLA and PFC subregions interact to control these
behavioral adjustments. Based on our experimental and computational work in the prior funding period, we
hypothesize that BLA provides information to different subregions of PFC to adjust learning under different forms
of uncertainty. Our central hypothesis is that BLA contributes to the arbitration between internal models
(stimulus vs. action-based) and between different forms of uncertainty (expected vs. unexpected
uncertainty) through its connections to OFC and ACC. Using a combination of computational methods,
pathway-specific chemogenetics, in vivo 1-photon (1P) single-cell calcium imaging, and closed-loop
manipulation, we will test how adopting an appropriate internal model (Aim 1) and adjustments to changes in
the environment (Aim 2) rely on BLA-to-OFC (BLAOFC) vs. BLA-to-ACC (BLAACC) pathways. We further causally
test these circuits by closed-loop control of learning based on both reward-expectation signals in ACC and OFC
at the neuronal ensemble level, which we can decode in real time, and behaviorally using our novel information-
theoretic metrics and postural measures (Aim 3).

Public health relevance
NARRATIVE Individuals with Substance Use Disorder often demonstrate a lack of consistency in choices, especially in the context of uncertainty. Our experiments are aimed at studying and manipulating the brain signals associated with learning under different forms of uncertainty using high-resolution tools and algorithms.